R-loop-induced DNA damage during immunoglobulin class switch recombination

Project Summary/Abstract

Class switch recombination (CSR) is a genetic process where a B cell switches antibody isotype
production through site-­specific intra-­chromosomal DNA rearrangement stimulated by the formation
of DNA double-­strand breaks (DSBs) at the immunoglobulin heavy chain (IgH) locus. DSBs are
normally repaired by the non-­homologous end-­joining (NHEJ) and alternative-­end joining (alt-­EJ)
DNA repair pathways. During CSR, DSB formation is highly regulated involving a complex interplay of
transcriptional activation, protein recruitment and chromatin reorganization. Understanding the factors
regulating DSB formation and repair has a high impact on lymphomagenesis. R loops are three
stranded RNA:DNA hybrid structures formed at IgH during CSR. While R loops are implicated in
promoting DSB formation at IgH, their role in class switch recombination remains undefined. We find
that mice defective for R loop removal are proficient at class switch recombination, however B cells
contain unrepaired breaks and chromosome fusions at IgH. Recurrent oncogenic translocations
involving IgH distinguish many human lymphoid malignancies. These translocations originate from
mis-­repaired DNA double stand breaks (DSBs) generated during normal lymphocyte development.
Our goal is to determine how persistent R loops impede DNA repair during CSR, and the role R loop
metabolism plays in suppressing genome instability at IgH. We hypothesize that persistent R loops
block efficient DNA repair by non-­homologous end joining at the immunoglobulin heavy chain
locus during class switch recombination, leading to persistent, unrepaired breaks. To test this
hypothesis, two mouse models will be employed: the SETX mutant lacks the Senataxin (SETX)
helicase that unwinds R loops;; and Rnaseh2b is defective for the RNase H2 nuclease that specifically
digests the RNA component of R loops (RNH2B). We will functionally dissect the consequences of
aberrant R loop formation on DNA repair and chromosome fusions arising during CSR in SETX-­/-­,
RNH2Bf/f, and SETX-­/-­ RNH2Bf/f cells (Aim 1). To define the impact persistent R loops have on NHEJ,
we will characterize DNA repair protein recruitment in SETX-­/-­, RNH2Bf/f, and SETX-­/-­ RNH2Bf/f cells
(Aim 2). We will also identify genomic loci involved in IgH translocations using high-­throughput
genome-­wide translocation sequencing (HTGTS-­Seq), in collaboration with Dr. Feyredoun
Hormozdiari. Finally, we will define the molecular pathways driving the frequent chromosome fusions
observed in SETX-­/-­ RNH2Bf/f cells (Aim 3). Our work will define how persistent R loops interfere with
class switch recombination, leading to unrepaired breaks, and will uncover the molecular
mechanisms promoting chromosome fusions at IgH. Enzymes regulating R loop metabolism will also
provide an attractive target for developing novel cancer treatment.

Public health relevance
Public health relevance Defective repair of DNA damage causes the accumulation of mutations and genomic rearrangements that predispose to cancer development. Setx and RNase H2 protect against immunoglobulin (Ig) translocations driving many lymphoid cancers. Understanding the impact of defects in Senataxin and RNase H2 on the formation of genomic mutations and rearrangements will provide novel and important insights into the molecular events driving tumorigenesis.